Improving Therapeutic Approaches for RAS-driven Rhabdomyosarcoma

Summary
Despite the use of aggressive chemo-radiation therapy, children with high-risk rhabdomyosarcoma (RMS)
including advanced or metastatic embryonal RMS (ERMS) with RAS mutations, have very poor outcomes (20-
30% survival at 5 years from diagnosis) with no significant improvement over the last 30 years. Further, current
multimodality therapies are associated with life-long life-threatening sequelae. This project focuses on
developing less-genotoxic, targeted therapy for RAS-mutant ERMS. Preliminary data support rapid translation
of vertical targeting of the MAPK pathway as a therapeutic approach in ERMS. The proposed aims are based
upon the following observations: (i) In RAS-driven ERMS, resistance to MEK inhibitors is a consequence of
pathway reactivation through CRAF; (ii) Combination of new generation type 2 RAF inhibitors with MEK inhibitors
cause dramatic regressions of most RAS-mutant ERMS PDX models but are not curative. Consequently, both
intrinsic and acquired resistance will be a barrier for long-term curative outcomes; (iii) Innovative single mouse
testing (SMT) experimental design shows that, consistent with their high-risk classification, RAS-mutant ERMS
PDX/CDX models, rapidly fail intensive multidrug regimens used in the most recent high-risk RMS clinical
protocol (ARST0431). Therefore, this project aims to: 1) define mechanisms of innate and acquired resistance
to co-targeting RAF and MEK in RAS-driven ERMS with the goal to facilitate more impactful clinical outcomes.
Using DNA and RNA sequencing, we will identify genomic/epigenomic changes associated with resistance and
validate and define mechanisms of innate and acquired resistance to combining type 2 RAF and MEK inhibitors
in ERMS; 2) evaluate how this approach can be integrated into current clinical chemotherapy protocols using
the SMT experimental design. Our studies will inform biomarkers of response to type 2 RAF + MEK inhibitors
combination and how this combination can be sequenced relative to chemotherapy to optimize responses of
RMS PDX/CDX models, thus directly impacting clinical trials design for RAS-driven ERMS.

Public health relevance
Narrative Eighty percent of children with advanced or metastatic sarcoma will die from disease despite aggressive multimodality therapy. In this proposal we aim to define less-toxic and more effective targeted therapeutic approaches in high-risk RAS-driven Embryonal Rhabdomyosarcoma (ERMS) by using patient-derived xenograft models, omics and novel single-mouse testing approaches. Our focus is inhibition of MAPK signaling as potential therapeutic strategy to treat ERMS.